Coordinating Center for Population-based Research to Optimize Cancer Screening (PROSPR) (U24)

Project Summary
Cancer screening is a complex, multi-step process where benefits are maximized when each step is completed
successfully, but where sub-optimal outcomes are frequent as a result of breakdowns that can happen at any
point in this process. Screening is also impacted by factors beyond simply individual patients—including factors
at the provider-, practice-, and health plan/institution-level—and these so-called systems level factors can
impact the appropriate delivery of high quality cancer screening services. PROSPR was established to address
a number of critical questions related to the delivery of cancer screening in the United States, and our
PROSPR I Statistical Coordinating Center was central to many of the successes of this initiative including: 1)
Developing a trans-organ conceptual model of cancer screening processes, 2) Creating common data
elements and screening performance metrics, 3) Evaluating individual and systems-level factors impacting
screening performance, 4) Authorship and statistical support on 21 trans-network published papers, 2 under
review, and 17 in preparation; and 5) Establishing PROSPR data repositories and creating an infrastructure for
publicly sharing PROSPR data. Our PCC team has considerable expertise both in the leadership of large
coordinating centers and in each of the scientific fields relevant to PROSPR including health services/health
care delivery, implementation science, cancer epidemiology, health disparities research, biostatistics,
bioinformatics/health information technology, and the screening of colorectal, cervical, and lung cancers. Thus,
we are uniquely positioned to successfully execute all components of this coordinating center. The specific
aims of our PCC are to: 1) Provide administrative coordination for the PROSPR network and guidance in the
development of PROSPR’s governance, organization, and policies/procedures; 2) Lead the development of
common conceptualization and measures for: A. Assessing the role of systems-level factors that impact the
screening process. B. Assessing screening quality; 3) Facilitate trans-PROSPR research comparing the
screening process across at least 2 organ sites; and 4) Develop and implement processes and procedures to
share PROSPR data with qualified investigators outside of the PROSPR network. RELEVANCE: Improving
both the screening process and screening quality for cervical, colorectal, and lung cancers will reduce
mortality, morbidity, and health care costs associated with these cancers in the United States.

Public health relevance
Project Narrative This PROSPR II Coordinating Center proposal builds upon the numerous successes of our leadership of the PROSPR I Statistical Coordinating Center. Our outstanding multidisciplinary team of investigators has considerable experience both in leading multiple coordinating centers and in conducting research on screening for cervical, colorectal, and lung cancers. The specific aims of our proposal are to: 1. Provide administrative coordination for the PROSPR Network, 2. Lead the development of common measures for systems-level factors that impact the screening process and screening quality, 3. Facilitate trans-PROSPR research, and 4. Develop and implement processes to share PROSPR data.